Mitochondrial-based Determinants of Sex Differences in Acute Kidney Injury

Acute kidney injury (AKI) afflicts substantial numbers of hospitalized patients, particularly those who are critically
ill. Because protection from AKI in females is observed both clinically and in animal models, a better elucidation
of the underlying biology of this protection may be essential to providing novel, effective intervention to both
females and males with AKI. In support of a sex-based susceptibility to AKI, we have shown that female mice
undergoing cisplatin-induced AKI (CP) have preserved renal function compared to males, which have
significantly worse AKI. Clarity in the mechanisms that underpin resistance of females to renal injury has the
potential to illuminate unique pathological mechanisms and represents a critical gap in our knowledge.
Mitochondrial dysfunction is noted consistently as a contributor to the outcomes of AKI, and estrogen alters
mitochondrial bioenergetics, perhaps via estrogen receptors that may be present in mitochondria. The primacy
of mitochondrial function in sex-defined susceptibility will be confirmed in this proposal by examining a novel
mouse model, developed at our institution, of mitochondrial-nuclear exchange (MNX) (Aim 1). These mice have
an exchange between two strains of mice such that the MNX mice have nuclear characteristics of one strain of
mice and the mitochondrial characteristics of another strain of mice. Our preliminary data demonstrate that the
parental strains of the MNX mice have different sex-based profiles in susceptibility to AKI allowing for the
investigation of the influence of these organelles in an injury model. A second modulation of mitochondrial
function will be examined with thermoneutrality, the ambient temperature at which no additional mitochondrial
shunting to heat generation is required to maintain core body temperature. Standard vivarium temperatures are
typically at ~22-23C (TS), while thermoneutral temperatures for rodents is ~30C (TT). Thermoneutrality alters
sex-differences in other organ systems, but has not been studied in AKI and will be examined in these studies
(Aim 2). Examination of changes in mitochondrial function with administration of estrogen or testosterone to
modulate susceptibility to AKI have not investigated long-term hormone administration. Long-term administration
of hormones, particularly cross-sex administration reflecting the status of transgender individuals, has been
minimally studied, and not at all in the kidney (Aim 3). The integrated overall hypothesis is that mitochondrial
bioenergetics and dynamics alters susceptibility to AKI in a sex-specific manner. In establishing how sex
differences are modulated in these different paradigms, these studies will provide the baseline understanding
needed to better define “female AKI” and determine nuanced differences that may be exploited in interventions.

Public health relevance
Acute kidney injury (AKI), which occurs more frequently in males than in females, remains therapeutically challenging and its long-term effects leading to progressive chronic kidney disease are costly. Unique paradigms, that may provide new therapeutic targets, modulate this protection and form the basis of this proposal.